Computing/IT Core

PROJECT SUMMARY
Computer technology is now an integral part of research. They are vital for all routine tasks, such as
communication, lab management, and database searches. Every lab uses computers to acquire, store and
analyze data. Additionally, many UCSF vision labs use computers experimentally to present visual stimuli and
to record neuronal responses from the retina or brain. Even more so needed in the laboratory where there is
specialized equipment with dedicated software, organizational IT infrastructure, experimental rigs, and analysis
workstations with specific requirements to work with. The computer/IT core provides outstanding computer
and IT support, programming, and teaching by an experienced technician; as well as a centralized database
for collaborative use of validated programs both within UCSF and throughout the vision community.

Public health relevance
PROJECT NARRATIVE The Computer/IT core provides outstanding computer and IT support, programming, and teaching by an experienced technician; as well as a centralized database for collaborative use of validated programs both within UCSF and throughout the vision community.